Data Management and Statistical Core

The primary objectives of the Data Management and Statistics (DMS) Core are to provide data
management and statistical support to the cores and affiliated projects of the University of Washington
Alzheimer's Disease Research Center (UW ADRC). The DMS Core computer and data management
specialists construct, modify, and maintain the databases needed to store, integrate, and access the UW
ADRC data across cores and from outside sources, while ensuring up-to-date computer security. They write
the code for seamless integration and data flow between computers and databases that are in the individual
laboratories, and for developing new computer tools and electronic data capture and data sharing procedures.
They coordinate all data flow and data corrections; carry out data quality control and quality assurance
analyses; collaborate with other cores to make necessary data corrections, and submit data to the National
Alzheimer's disease Coordinating Center for sharing with other investigators. They also develop data
representations and data access procedures, and collaborate with other cores to derive attributes of the data
that are used for data queries. The DMS Core statisticians are available to all cores, development projects, and
affiliated projects for consultation and assistance regarding statistical design, analysis, and interpretation of
data, and to initiate new collaborations. They also assist in manuscript preparation and, when needed,
evaluate, develop and/or implement new analytical methodology as working software.
The specific aims are: (1) To provide data management support for projects, cores, affiliated projects and
development projects. This includes ensuring database entry of all Clinical Core data; timely upload of clinical,
neuropathology, and targeted genotyping data to NACC; tracking and monitoring of data completion and
quality; coordination of data flow between cores; coordinating and processing of data corrections; development
of data extraction tools; and maintenance and continued development of the databases. (2) To provide
statistical support for projects, cores, development projects and affiliated projects of the UW ADRC. This will
include providing statistical consultation on design, analysis, and interpretation of results; carrying out data
analyses; assisting with associated manuscript preparation; and evaluating and extending statistical
methodologies. (3) To maintain the computing environment needed to achieve aims 1 and 2.
The Data Management and Statistics Core of the UW ADRC will provide the necessary data management
assistance needed to efficiently and accurately store and retrieve the data collected by the center. Through
assistance with statistical data analysis it will also facilitate the translation of data into scientific discoveries
relevant to the prevention, treatement or diagnosis of Alzheimer's disease. In doing so, the DMS Core will
facilitate the overall goals of the UW ADRC in its mission toward reducing the burden of Alzheimer's disease.